Core 3: Epigenomics Core

Project Summary (Core 3) The overall goal of the program is to study the key features of epigenetic circuitry in myeloma and improve our understanding of global gene regulation to deploy novel therapeutics that target key epigenomic circuits. Cells and cell states can be defined by their gene expression programs, and tumor cells commonly have deregulated gene expression programs. This core will perform epigenomic analyses on clinical samples from Projects 1, 2, and 4, as well as preclinical samples in Project 2 and 3. Specifically, samples will be obtained from patients enrolled on the clinical trial (N=1260) evaluating an MRD-based therapeutic algorithm at time of diagnosis (Project 1 and 2) and at relapse (Project 4). In each case, tumor cells will be isolated in Core 2 using well established procedures. This core (Core 3) will perform analysis for select master transcription factors, their chromatin cofactors, and the enhancer element marks. The core has capabilities to perform ChIP-seq using low cell number (5000 cells; van Galen et al, Molecular Cell 2016 Jan;61(1):1-11), perform Single-cell ChIP- seq (Rotem A et al Nat Biotechnol. 2015 Nov;33(11):1165-72) as well as adopt innovative variations specifically needed to answer questions. The core will help accurately chart maps of histone modifications and related chromatin structures.

Public health relevance
Project Narrative (Core 3) The mission of this Core is to provide data on epigenomic profile in clinical and preclinical samples using a standardized approach.